Phase 1 Study of Pc 4 Photodynamic Therapy for Tx of Cutaneous T-Cell Lymphoma

DESCRIPTION (provided by applicant): The overall goal of this project is to determine the clinical and cellular/molecular effects of PDT using Pc 4 on stage 1A-2A CTCL/MF. CTCL is a rare cutaneous malignancy with a prevalence of less than 200,000. It is hypothesized that topically applied Pc 4 followed by red light is a saf and tolerable treatment for early stage CTCL/MF. The aim is to demonstrate both clinical safety and tissue biological effects using skin biopsies of Pc 4-PDT treated versus untreated control lesions. These biopsies will be analyzed at the gene and protein expression level to determine potential biomarkers of response to PDT in CTCL, that can be used to optimize future protocols for Phase 2 and 3 clinical trials. The known photostability of Pc 4 will be utilized by evaluating the benefits of repeated photoexposures. This will be aided by an in vivo imaging device that measures Pc 4 levels in real time in skin lesions through fluorescence spectroscopy.

Public health relevance
Project Narrative Cutaneous T-cell lymphoma (CTCL) of the Mycosis Fungoides (MF) variant is a rare but serious skin malignancy. Unlike other skin cancers such as epithelial carcinomas that can be surgically removed, CTCL is a chronic recalcitrant condition that appears initially as eczema-like patches and plaques, prior to progression into tumors or even a leukemic stage with significant morbidity and a 3-year median survival. The presentation of CTCL is such that it is not amenable to surgical removal. It also involves an unclear etiology and a complex pathogenesis, which makes the management of this disease even more difficult. In fact, only a select number of dermatologists are comfortable and well-versed in managing CTCL/MF. Current treatment options are not consistently effective. Some of the approved drugs are also very expensive (e.g. topical and systemic retinoids, dinileukin diftitox or Ontak(R), vorinostat or Zolinza(R)) and have the potential for numerous side effects (e.g. immunosuppression, risk for other malignancies, cardiotoxicity, etc). Hence, there is clearly a need to develop therapies for CTCL that are safe, effective, and affordable. This study aims to address that need by initiating a Phase I controlled clinical trial on silicon phthalocyanine Pc 4 for photodynamic therapy (PDT) of early stage CTCL (IA-IIA). This modality involves a simple topical application of the photosensitizer Pc 4, followed by photoexposure to 675 nm red light. Pc 4-PDT has already been shown safe and tolerable in an initial study of 43 patients with various skin neoplasms. It has also been found safe and tolerable in an ongoing Phase 1 clinical trial for psoriasis in which 17 subjects have been treated to date. A clinical trial focused on CTCL/MF, with mechanistic studies, will enhance the development of this therapy, and will pave the way for new strategies in the management of this rare but debilitating disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The overall goal of this project is to develop photodynamic therapy (PDT) using the silicon phthalocyanine Pc 4, in the treatment of mycosis fungoides (MF)-type cutaneous T-cell lymphoma (CTCL). MF is a rare but serious skin disease characterized by homing of atypical T-cells into the epidermis. There is currently no therapy for MF that has high efficacy and without adverse effects. We will perform a Phase I trial of topically- applied Pc 4 and red photoactivating light, followed by clinical assessment and evaluation of tissue responses to PDT via histology/immunohistochemistry, RT-PCR, and targeted proteomic analysis to monitor PDT-induced oxidative stress and apoptosis. Integration of clinical and laboratory-generated data will provide mechanistically-based guidance in developing the safe and effective use of Pc 4-PDT for MF. Specific Aim 1. To confirm the safety and tolerability of Pc 4-PDT in stage IA-IIA CTCL-MF type. From a prior Phase 1 trial that enrolled 43 patients with various skin neoplasms, we found that a single treatment with Pc 4-PDT is well tolerated in MF and results in partial clinical response. Maximum tolerated dose (MTD) was not reached at the highest level tested, i.e. 0.1 mg/ml Pc 4 and 200 J/cm2 of light. We hypothesize that an accelerated titration protocol will establish the safety and tolerability of Pc 4-PDT through 1 mg/ml of Pc 4 and 200 J/cm2 of light, which we consider are the practical upper limits of drug and light dose in the clinical setting. In a cohort of 18 MF patients with at least two similar evaluable lesions each, we will determine if the MTD of Pc 4-PDT will be reached under these conditions. We will monitor treatment-induced discomfort, local skin reactions, as well as systemic safety and toxicity parameters that are required of Phase I clinical trials. We will also monitor lesion response clinically, by assessing the area, erythema, and thickness/induration. Specific Aim 2: To determine whether multiple photoexposures of Pc 4-treated lesions augments the efficacy of Pc 4-PDT without enhancing toxicity. In vivo spectroscopy during photoirradiation MF revealed significant residual Pc 4 at the end of the treatment, likely due to the known photostability of this compound. .Using skin biopsies, we have found that some photoactivatable Pc 4 remains in skin lesions at 4 hours after PDT. Furthermore, recent data from psoriasis lesions indicated that fractionating the delivery of light (i.e. instituting a pause of several minutes during photoexposure instead of one continuous light delivery) enhances Pc 4 skin penetration without affecting safety and tolerability. We hypothesize that repeat photoirradiation of the lesion will enhance the tissue response to Pc 4-PDT. In a cohort of 6 MF patients, we will apply Pc 4 at the highest tolerated dose and light at 100 J/cm2 will be delivered up to a maximum of 3 times, or until there is no more detectable Pc 4 in the lesion, or until Grade 3 toxicity is observed, whichever occurs first. We will measure the Pc 4 amount in the lesion in vivo prior to each photoirradiation via non-invasive spectroscopy. We will monitor the skin lesion for local toxicity prior to each photoirradiation and conduct assessments for clinical response and safety parameters as in Specific Aim 1. Specific Aim 3: To evaluate Pc 4-PDT induced oxidative stress and apoptotic responses by analyzing changes in gene and protein expression from skin biopsies of treated versus untreated lesions. Our data from psoriatic skin lesions treated in vivo with Pc 4-PDT demonstrate significant changes in the oxidative stress-related genes GRP78 and HO1. Proteomic analysis of MF skin lesions after in vivo Pc 4-PDT showed significant upregulation of the p70S6K signaling pathway, a critical regulator of cell death and proliferation. We hypothesize that there is a safe range of Pc 4 and light doses that results in efficient oxidative stress and apoptosis that can be demonstrated in tissue samples obtained after PDT. Using the patient cohorts above, skin punch biopsies will be obtained from treated and untreated lesions 4- 24 hours after Pc 4-PDT for the single dose cohort, and after the last photoirradiation for the multiple photoexposures cohort. Samples will undergo immunohistochemical staining, RT-PCR and targeted proteomic analysis to determine changes in expression of genes relevant to oxidative stress responses and apoptosis at the RNA and protein levels. These data will be correlated with clinical and histologic outcomes. Whereas these correlates may not achieve statistical significance because of the accelerated titration design, the analyses at the level of MTD and for the multiple photoexposure protocol are expected to achieve sufficient power as there will be at least 6 subjects receiving the same treatment conditions. The results of the studies proposed herein will allow an efficient transition to Phase II and III clinical trials. Molecular changes observed may prove useful as early surrogates of response to treatment. All of these information will facilitate the clinical translation of Pc 4-PDT as a safe and effective therapy for CTCL.